Spatially Resolved Molecular Measurement of Biomolecular Condensates

PROJECT SUMMARY
Biomolecular condensates are diverse and abundant membrane-less organelles that partition the intracellular
environment into functionally distinct compartments containing specific sets of molecules and reactions.
Biomolecular condensates participate in various essential housekeeping, stress-response, or cell type-specific
processes. Furthermore, an increasing number of studies have linked the physiological state of a cell or the
spatial locations of condensates in a cell with the composition of the condensates. Thus, to understand the
functions of biomolecular condensates, it is important to know how the molecular content in the condensates
change in health vs. disease or in different spatial locations. In this proposal, we aim to develop a novel spatial
genomics platform that will enable multi-modal molecular characterization of biomolecular condensates at the
sub-micron scale. This will be revolutionary for studying the functional roles of biomolecular condensates in
cellular processes under homeostatic and pathological conditions. Our tools will enable us to look at the
genome, epigenome, and transcriptome within the condensates in a spatially resolved manner all under native
cell and tissue context. We will ensure these novel genomic tools are easy to use and adopt. The successful
completion of this work will lead to a comprehensive toolset for understanding cell and tissue biology from the
perspective of biomolecular condensates.

Public health relevance
PROJECT NARRATIVE Biomolecular condensates are membrane-less intracellular assemblies that play fundamental roles in cellular organization, physiology, and pathology. The functions of biomolecular condensates are closely linked to their molecular content. By developing a novel genomics platform for spatially resolved profiling of molecular contents within the condensates, we will provide novel insights into human health and disease through the lens of biomolecular condensates.